Common and Distinct Influences of Prenatal and Postnatal Early-Life Adversity on Epigenomic Trajectories in Mexican American Children

PROJECT SUMMARY
Childhood obesity is a growing public health epidemic that is disproportionally affecting Hispanic children and
associated with morbidity and downstream health disparities. Early-life adversity and childhood psychosocial
stressors have been shown to contribute to obesity risk, with stronger effects reported among children growing
up in lower-income households. The period of fetal development and early-life are marked by dynamic and rapid
changes in fetal DNA methylation programming, epigenetic maturation of immune system-related genes in early-
childhood and general physiological development. A poor and adverse social environment in early life has been
hypothesized to contribute to epigenomic “weathering” leading to accelerated decline in health, aging and
eventual health disparities, including obesity. A leading hypothesis for the origins of health disparities is the
biological embedding of adversity on the epigenome due to chronic adversity exposure. While emerging
evidence indicates that psychosocial stressors and adversity are associated with epigenetic biomarkers like DNA
methylation, significant limitations remain in the field. Namely, most studies to date have been cross-sectional,
used candidate gene approaches, not investigated changes or trajectories in epigenetic biomarkers throughout
development, or functional consequences in gene expression. The proposed project will leverage data and
samples from The Center for the Health Assessment of Mothers and Children of Salinas (CHAMACOS), a long-
term study of low-income Latinx, predominantly Mexican American, mother-child pairs living in the Salinas Valley
of California. We have repeated measurements and samples for DNA methylation analyses at birth, 7, 9, 14 and
18 years in approximately 300 mother-child pairs, genetics, and stabilized RNA for sequencing at 14 years of
age. We will investigate both pre- and postnatal early-life adversity measures to 1) determine if adversity
measures are associated with blood DNA methylation trajectories and subsequent variation in gene expression;
2) evaluate if adversity measures influence epigenetic aging clocks and biomarkers and their trajectories and if
longitudinal changes are prospectively associated with obesity risk; and 3) determine if DNA methylation or
epigenetic aging mediate associations with obesity and if an epigenetic adversity score can be constructed from
children’s blood methylome. Our study will address critical gaps in the field by testing hypotheses prospectively
over 18 years and addressing questions of persistence and embedment of pre- and postnatal adversity. We will
test if epigenetic changes influence gene expression with untargeted RNA sequencing at 14 years. We will
evaluate if DNA methylation can serve as a reliable biomarker of adversity in early-life and or alternatively if
these biomarkers are causal for the relationship between adversity and obesity risk with mediation and
mendelian randomization methods. Our approach will yield rigorous data to test the biological embedment of
social adversity and its consequences in a Latinx, low-income birth cohort with high obesity prevalence.

Public health relevance
PROJECT NARRATIVE In the U.S., the childhood obesity epidemic disproportionally impacts minority communities, particularly Hispanic children. Minority populations face multiple psychosocial stressors at the individual, household and community level that are associated with increased obesity risk. This research will establish the biological embedment of early-life adversity at the individual, household and community level on epigenetic marks, with the goal of developing early-life biomarkers of risk.